Cell-type specific assembly of apical extracellular matrices

Project Summary/Abstract
The development and function of tubular organs, including the lungs, intestines, and inner ear, depends
in part on an apical extracellular matrix (aECM) that lines the organ interior. aECMs contain many components
that are shared across organisms such as mucins, collagens, and zona pellucida domain (ZP) proteins. Matrix
proteins are often arranged into distinct layers or spatial domains within an organ; however, these structures
are often destroyed by fixation, limiting the ability to study how they are formed.
This proposal uses the well characterized and highly tractable model of the developing C. elegans
vulva to understand how aECM is specified and assembled. Due to its transparent body and the ease of
fluorescently tagging proteins, C. elegans is an ideal system to study aECM in a live organism. Many of the
aECM domains in the vulva are cell type specific, allowing us to directly connect the assembly of matrix
proteins to the biology of the cells they coat. This study focuses on two ZP matrix proteins, LET-653 and
NOAH-1, that localize to the matrix of specific vulva cells. Like ZP proteins in some other systems, such as the
mammalian inner ear, the localization of LET-653 and NOAH-1 is not well explained by their transcription
patterns. ZP proteins require protease cleavage to properly localize and must also bind surface factors at their
destination site. The identity of these ZP protein partners is unknown. Aim 1 will dissect the relative
contributions of each cell type to the expression, processing and export, and matrix localization of ZP proteins.
It will also identify the transcription factors required for cell type specific matrix fate. Aim 2 will identify
candidate ZP protein partners with differential expression between cell types by single nucleus RNA
sequencing (snRNA-Seq) and test their requirement for ZP matrix assembly. Ultimately, these experiments will
uncover a gene regulatory network that specifies apical matrix identity and identify ZP protein partners that
could be applicable to many systems.
This project is designed to provide training in epithelial and matrix biology, as well as relevant
techniques in single cell transcriptomics, genetics, and microscopy. It is sponsored by Dr. Meera Sundaram, an
expert in matrix biology and C. elegans vulva development, and co-sponsored by Dr. John Murray, an expert in
gene regulatory networks and single cell technologies in C. elegans. The research will be conducted at the
University of Pennsylvania, an institution with a collaborative and stimulating intellectual environment as well
as first-rate facilities and resources to conduct biomedical research. The proposed training plan incorporates
many professional development opportunities available through the university, sponsors, and C. elegans
community. At the conclusion of the proposed research and professional activities, the applicant will be
prepared for a career incorporating teaching undergraduates and running her own laboratory.

Public health relevance
Project Narrative The interior of many organs, such as the lungs and intestines, is line with an extracellular matrix critical to their function. Issues with this matrix contribute to many human diseases, including chronic obstructive pulmonary disease (COPD), ulcerative colitis, and many forms of cancer. This study will provide insight into how the components of this matrix are produced and coat the proper surfaces.